Mississippi Diversity in Hypertension and Cardiorenal Research Program

Mississippi is among the leaders in mortality due to heart disease, stroke, hypertension, diabetes mellitus, and
kidney disease. Mississippi also has the greatest health care disparities in the country along with limited
extramural research support necessary to recruit and retain top biomedical researchers that can address these
important issues. These widening health care disparities affect underrepresented minorities, including African
Americans and Hispanic Americans, who are disproportionately affected by heart disease, stroke, diabetes,
nephritis/nephrosis, hypertension and hypertension related renal diseases. Therefore, a unique opportunity
exists in Mississippi for building diverse research infrastructure to investigate mechanisms and new treatment
options for cardiovascular and renal diseases at the very location where they are most prominent in the United
States. This application proposes to continue a highly successful summer research program in the State of
Mississippi that increased the participation of individuals from underrepresented minorities (URM) in
hypertension, renal and cardiovascular related biomedical fields over the last five years. The Mississippi
Diversity in Hypertension and Cardiorenal Research Program (MSDHCR) supported over forty URM students
in the first funding cycle, with greater than 90% of graduates utilizing their science degree in graduate school,
professional school, or in their employment. The University of Mississippi Medical Center (UMMC) has a long
history of excellence in cardiovascular and renal research, and mentoring. The current proposal seeks an
additional five years for the MSDHCR program, and represents a critical component of the mission to train and
mentor cardiovascular and renal researchers. This competitive renewal includes enhanced institutional
support and innovative improvements that ensure the continued development of a robust biomedical pipeline.
The overall objective of this training program is to provide career and education mentoring along with state-of
the art cardiovascular and renal research training experiences to individuals with disadvantaged and
underrepresented ethnic or racial backgrounds in the cardiovascular and renal sciences. Undergraduate
students from disadvantaged and underrepresented backgrounds will participate in this program that has the
following aims: 1. To provide program participants a multi-disciplinary training and mentoring experience in
cardiovascular and renal research. 2. To provide program participants with opportunities for professional
development that will help them achieve careers in health-related research professions. 3. To provide
standardized test training for program participants that will prepare them for the next steps in their educational
training.

Public health relevance
Mississippi is among the leaders in health disparities in cardiovascular diseases that disproportionately affect individuals from disadvantaged and underrepresented racial and ethnic populations. At the same time, Mississippi lags in the development of a robust pipeline of biomedical researchers that can address these important issues. This grant proposes to continue a successful summer research training and mentoring program in cardiovascular research for undergraduate students from disadvantaged and underrepresented racial and ethnic populations in Mississippi.